The role of Wnt signaling in treating glucocorticoid-induced glaucoma

PROJECT SUMMARY/ABSTRACT
Glucocorticoid (GC)-induced ocular hypertension (OHT) and glaucoma (GIG) occur in ~40% of the general
population and ~90% primary open angle glaucoma (POAG) patients. Our published studies and preliminary
data show that canonical Wnt signaling activation inhibits glucocorticoid receptor signaling and GC-induced
OHT. We hypothesize that activation of canonical Wnt signaling inhibits GIG, and this inhibition requires nucle-
ar β-catenin, glucocorticoid receptor (GR), and epigenetic modification enzymes including HDAC1 and MeCP2.
In this supplemental application, our objective is to identify new epigenetic mechanisms of and therapeutic
compounds for glucocorticoid-induced OHT/glaucoma. Our rationale is that Wnt activation is a potential ap-
proach to prevent and treat OHT/GIG, and studying GIG will help us to better understand primary open angle
glaucoma. We propose two specific aims. SA 1: Determine whether G-quadruplex is regulated by the glucocor-
ticoid receptor (GR) signaling pathway in the trabecular meshwork (TM). Recently, emerging evidence showed
the importance of a DNA secondary structure, G-quadruplex (G4) in many biological processes. We hypothe-
size that GCs enhance G4 formation in the TM. We will treat primary human trabecular meshwork (pHTM) cells
from glucocorticoid responders or non-responders with or without 100nM DEX or 0.1% ethanol for 1 day. The
cells will be used for immunoprecipitation against G4 chromatin, and purified DNA containing G4 will be used
for DNA sequencing. At least 3 glucocorticoid responder and non-responder TM cell strains will be tested. We
expect to find that glucocorticoid-responder TM cells have more G4 structures and these G4s are associated
with key genes such as cell survival and ECM metabolism. We also expect to find that glucocorticoids enhance
G4 formation and this enhancement is greater in responder TM cells. SA 2: Identify novel Wnt signaling path-
way activation compounds with high potency in inhibiting GR signaling in the TM. We have found that the acti-
vation of the Wnt signaling pathway using a small molecule compound CHIR is effective in the inhibition of GR
signaling. Our preliminary data from the parent R01 also showed that CHIR did not compromise DEX’s anti-
inflammatory effects in mouse eyes with endotoxin-induced uveitis. However, CHIR needs to be applied at high
concentrations. Therefore, it is important to find more potent small molecule Wnt signaling activators. The pro-
posed study is significant because it provides new molecular mechanisms as well as therapeutic targets for the
prevention and treatment of glucocorticoid-induced OHT/glaucoma. The findings, especially from SA2, will
have translational applications. It is also innovative because the role of G4 in the TM, glaucoma, and glucocor-
ticoid receptor signaling, to our best knowledge, is completely unknown. Our future studies will focus on 1)
whether G4 can be inhibited by Wnt signaling; 2) validation of the downstream target of glucocorticoid-induced
G4 in the TM; and 3) testing the compound hits in vivo.

Public health relevance
PROJECT NARRATIVE Glucocorticoid-induced ocular hypertension and glaucoma are the most common ocular complications of prolonged glucocorticoid use, which may lead to irreversible blindness. This project is relevant to public health because it focuses on how the distal aqueous humor outflow pathway tissues contribute to this disease. Therefore, the proposed research is relevant to the part of NEI’s mission that pertains to developing fundamental knowledge with respect to blinding eye diseases.